BLRD Research Career Scientist Award Application

ABSTRACT
Nearly 63 million people (20% of the US population) are eligible for VA benefits and services because
they are veterans, family members or survivors of veterans. Cardiovascular diseases (CVD) contribute to
significant morbidity and mortality of the military veterans and civilians (CDC/National Center for Health
Statistics). I have been associated with VA and non-VA funded clinician-scientists and basic researchers for
the past 25 years. I am also a VA funded investigator. The overall focus of my research as a VA funded
scientist is to investigate the causal role of inflammation, inflammatory cytokines and chemokines, and
inhibitors of inflammation in CVD. Since inflammation is a critical component in the pathogenesis of CVD, and
CVD are the major contributing factors for morbidity and mortality within both military veteran and civilian
populations of both sexes, my studies are highly relevant to the VA mission. Since hypertension, diabetes,
obesity, and smoking predispose veterans and civilians alike to CVD, my ongoing studies are timely and critical
in further understanding the molecular mechanisms underlying the pathophysiology of these chronic diseases.
Using the most promising research strategies and problem-solving approaches, my goals are to identify newer
therapeutic targets and approaches to blunt progression of CVD and associated mortality. We identified two
molecule that show promise: TRAF3IP2 and RECK. TRAF3IP2 (TRAF3 Interacting Protein 2) is a cytoplasmic
adapter molecule and an upstream regulator of at least three major proinflammatory signal transduction
pathways that are known to play a pathological role in ischemic/non-ischemic cardiac diseases. TRAF3IP2 is
an upstream regulator of IKK/NF-kB, JNK/AP-1 and p38 MAPK, whose persistent activation exerts negative
myocardial inotropic effects. It also induces the expression of collagens and MMPs. TRAF3IP2 is also a critical
intermediate in IL-17, IL-18 and TLR4 signaling, all of which are involved in HF development and progression.
RECK (Reversion Inducing Cysteine Rich Protein with Kazal Motifs) is a membrane anchored MMP regulator.
It also exerts anti-inflammatory effects by physically associating with ADAMs, and IL-6R and gp130. Our
preliminary data show that human heart failure of ischemic/non-ischemic origin (explanted hearts) is
characterized by high levels of TRAF3IP2 and suppressed expression of RECK. Therefore, my goal and
passion are to work towards developing TRAF3IP2 inhibitors and RECK inducers and investigate their
potential in blunting the progression of heart failure in preclinical models. Towards this goal, using molecular
modeling and docking, we tested several thousands of compounds, and identified two potential small molecule
TRAF3IP2 inhibitors and one small molecule RECK inducer, and submitted invention disclosures to VA and the
affiliate. Since RECK expression is downregulated in human heart failure, my ongoing studies are focused on
investigating whether RECK induction blunts pressure overload-induced adverse myocardial remodeling and
heart failure in preclinical models. Utilizing both in vivo (genetic and interventional) and in vitro (cardiomyocytes
and cardiac fibroblasts) models, I will determine the relationship between RECK, MMPs, ADAMs, and
inflammation and heart failure (HF) of non-ischemic origin in vivo and the molecular mechanisms underlying its
reduced expression in vitro (VA Merit 2022-2026). We are also exploring whether AAV9-cTnT (truncated
cardiac troponin promoter)-mediated RECK overexpression, specifically in cardiomyocytes, will inhibit the
progression of heart failure in a preclinical model. In addition, my ongoing studies are focused on unraveling
the roles of the RNA binding protein Larp6 (stimulates collagen I expression) in adverse cardiac remodeling
and HF development.

Public health relevance
Project Narrative Cardiovascular diseases (CVD) are the major causes of morbidity and mortality in veterans. For two decades, my research focused on dissecting the molecular mechanisms underlying the initiation and progression of inflammatory CVD, has identified four potential therapeutic targets: IL-18 (Interleukin-18), TRAF3IP2 (TRAF3 Interacting Protein 2), Larp6 (La Ribonucleoprotein Domain Family Member 6), and RECK (Reversion Inducing Cysteine Rich Protein with Kazal Motifs. Increased expression of IL-18 and TRAF3IP2 play a causal role in myocardial injury, adverse cardiac remodeling, and HF development. Larp6, a RNA-bing protein, plays a role in collagen synthesis. RECK inhibits multiple mediators involved in adverse cardiac remodeling. My goal of determining if neutralizing IL-18, inhibiting TRAF3IP2 or Larp6, or inducing RECK can blunt progression of CVD is highly relevant to veterans and the mission of the Veterans Health Care System.